The role of mesothelial-derived cancer-associated fibroblasts in the pathogenesis of pancreatic ductal adenocarcinoma

PROJECT SUMMARY
Pancreatic ductal adenocarcinoma (PDA) is a deadly disease with a five-year survival rate of 12%. Oncogenic
KRAS (Kras*) is a near-universal driver of PDA, and its activity is required for the formation of the PDA precursor
lesions, pancreatic intraepithelial neoplasia (PanIN). PanIN formation is accompanied by fibrosis and immune
cell infiltration that is maintained and evolves throughout disease progression. Cancer-associated fibroblasts
(CAFs) have known roles in modulating the function of immune and cancer cells via intercellular interactions.
Displaying high degrees of heterogeneity, CAFs have tumor-promoting and tumor-restraining functions that are
thought to be mediated by distinct fibroblast populations. Data from other labs suggest that differential origins of
CAFs play a role in programming this heterogeneity. Notably, mesothelial cells, a protective monolayer of cells
that lines internal organs, are a potential, understudied source of CAFs in PDA. Preliminary experiments
described in this proposal demonstrate that in orthotopic mouse models of PDA, mesothelial cells give rise to
CAFs. Moreover, our group found that a potential population of WT1+ mesothelial-derived CAFs comprise a
transcriptionally distinct population of fibroblasts expressing high levels of cytokines with known
immunomodulatory roles in PDA. Consistent with this observation, depletion of WT1+ cells reduced expression
of these cytokines in orthotopic tumors that coincided with a reduction in tumor weight. Interestingly, an increase
in immunosuppressive macrophage infiltration was observed upon WT1+ cell depletion, suggesting that this
reduction in tumor weight can be augmented by macrophage-targeting therapeutics. Compatible with the
hypothesis that origin dictates CAF function, the overall objective of this study is to characterize sources of
CAF heterogeneity, identifying novel approaches to selectively target tumor-promoting properties of CAFs in
PDA. The central hypothesis is that mesothelial cells give rise to functionally distinct, immunomodulatory CAFs
in PDA. This hypothesis will be investigated through the following two Aims: (Aim 1) Determine the contribution
of WT1+ mesothelial cells to the fibroblast compartment in the context of PDA, and (Aim 2) Evaluate the
functional role of WT1+ cells at different stages of PDA pathogenesis. To complete this investigation, a
combination of in vivo models and in vitro assays, including macrophage polarization and migration assays, will
be used to determine the properties of mesothelial-derived CAFs and their functional roles in the PDA tumor
microenvironment. The data accumulated by this study will further the field's understanding of how cell origin
dictates fibroblast function in PDA and pave the way for development of novel fibroblast-targeting therapeutics.

Public health relevance
PROJECT NARRATIVE Pancreatic cancer is characterized by the expansion of heterogenous cancer-associated fibroblasts (CAFs) that are believed to play tumor-promoting and tumor-restricting roles in disease progression; this heterogeneity is programmed, in part, by the diverse cellular origins of CAFs. Preliminary evidence suggests that mesothelial cells give rise to a phenotypically and functionally distinct class of CAFs in pancreatic cancer. Thus, the goal of this proposal is to investigate the quantitative and qualitative contribution of mesothelial-derived CAFs to the pancreatic tumor microenvironment, and to ascertain their functional role in disease progression.